The Affordable Care Act: MCV/PCV & Pertussis

DESCRIPTION (provided by applicant): The Maryland Emerging Infections Program (MD EIP) is a working partnership among Maryland's state health department (the Maryland Department of Health and Mental Hygiene), the Johns Hopkins University Bloomberg School of Public Health (JHSPH), and the University of Maryland, College Park (UMCP). Maryland became a national EIP network member site in 1997, and over the ensuing thirteen years, has developed into a mature partnership capable of performing active, laboratory-based surveillance using defined surveillance populations;conducting applied public health epidemiologic and laboratory activities;and implementing and evaluating pilot prevention and intervention projects. The MD EIP is also capable of rapidly responding to emerging infectious disease threats, as was demonstrated during the 2003-2004 and subsequent influenza seasons. Through this application, the MD EIP is requesting funding to support: (1) overall program infrastructure;(2) influenza epidemiology and laboratory capacity;and (3) surveillance for bloodstream infections among dialysis patients in out-patient settings. The first initiative will provide support for scientific leadership and further collaboration with the University of Maryland School of Public Health;provide training opportunities for program epidemiologists and informatics staff;fund a seminar to provide EIP surveillance and study findings to infection preventionists, clinical laboratorians, and local health department staff;and support other EIP infrastructure needs. The second initiative will provide the state public health laboratory with additional resources for conducting RT-PCR testing to confirm influenza infections during the upcoming seasons. In addition, the MD EIP will collaborate with CDC and the other EIP sites to develop a model that will provide interim estimates of the number of influenza cases, hospitalizations, and deaths as an influenza season unfolds. These activities will contribute to the DHMH influenza response program. The third initiative will complement the healthcare-associated infections (HAI) projects currently being conducted through the EIP and the Epidemiology and Laboratory Capacity (ELC) cooperative agreements. Dialysis patients are known to have high rates of bloodstream infections. This EIP project will develop capacity among dialysis centers to report data on bloodstream infections through the National Healthcare Safety Network (NHSN) dialysis module. This data will be used to develop prevention initiatives, assist the dialysis centers in meeting the CMS reporting requirements for the incidence of infection, and provide a model for other states to use in dialysis centers.

Public health relevance
Maryland Emerging Infections Program Patient Protection and Affordable Care (PPACA) Enhancing Epidemiology and Laboratory Capacity Introduction The Maryland Emerging Infections Program (MD EIP) is submitting this application in response to the Funding Opportunity Announcement (RFA-CI-10-003) entitled "Patient Protection and Affordable Care Act (PPACA): Emerging Infections Program (EIP) Enhancing Epidemiology and Laboratory Capacity". The Maryland Department of Health and Mental Hygiene (DHMH) is one of ten state health departments currently receiving funding through the Emerging Infections Program cooperative agreement with the Centers for Disease Control and Prevention (CDC) to conduct enhanced public health surveillance and applied public health research. The MD EIP is a working partnership among Maryland's state health department (DHMH), the Johns Hopkins University Bloomberg School of Public Health (JHSPH), and the University of Maryland School of Public Health (UMSPH). Maryland became a national EIP network member site in 1997, and over the ensuing thirteen years, has developed into a mature partnership capable of performing active, laboratory-based surveillance using defined surveillance populations; conducting applied public health epidemiologic and laboratory activities; and implementing and evaluating pilot prevention and intervention projects. The MD EIP is also capable of rapidly responding to emerging infectious disease threats, as was demonstrated during the 2003-2004 and 2009-2010 pandemic H1N1 influenza seasons. Through this application, the MD EIP is requesting funding to support: (1) overall program infrastructure; (2) influenza epidemiology and laboratory capacity; and (3) surveillance for bloodstream infections among dialysis patients in out-patient settings. The first initiative will provide support for scientific leadership and further collaboration with the recently accredited University of Maryland School of Public Health; provide training opportunities for program epidemiologists and informatics staff; fund a seminar to provide EIP surveillance and study findings to infection preventionists, clinical laboratorians, and local health department staff; and support other EIP infrastructure needs. The second initiative will provide the state public health laboratory with additional resources for conducting RT-PCR testing to confirm influenza infections during the upcoming influenza seasons. In addition, the MD EIP will collaborate with CDC and the other EIP sites to develop a model that will provide interim estimates of the number of influenza cases, hospitalizations, and deaths as an influenza season unfolds. These activities will contribute to the state and national influenza response programs. The third initiative will complement the healthcare-associated infections (HAI) projects currently being conducted through the EIP and the Epidemiology and Laboratory Capacity (ELC) cooperative agreements with CDC. Since dialysis patients are known to have high rates of bloodstream infections, this EIP project is designed to develop capacity among dialysis centers to report data on bloodstream infections. The data will be used to develop prevention initiatives, assist the dialysis centers in meeting the Centers for Medicare and Medicaid Services reporting requirements for the incidence of infection, and provide a model for other states to use in dialysis centers. Infrastructure (Activities 1, 2, and 3) Background and Understanding The Maryland Emerging Infections Program (MD EIP) is a working partnership among Maryland's state health department (DHMH), the Johns Hopkins University, Bloomberg School of Public Health (JHSPH), and the University of Maryland, School of Public Health (UMSPH). Staffing includes physicians, nurses, infection preventionists, epidemiologists, surveillance officers, microbiologists, molecular biologists, and a biostatistician. Community-based partners of importance to the success of the MD EIP include infection preventionists in approximately 60 hospitals in Maryland and the surrounding jurisdictions; microbiologists and other laboratory scientists from approximately 80 clinical laboratories licensed to conduct business in the state; and communicable disease staff in 24 local health departments. These collaborative relationships, developed over the past 13 years of the MD EIP, have supported the implementation of active, laboratory-based surveillance using defined surveillance populations; enabled applied public health epidemiologic and laboratory activities to be conducted; and the evaluation of pilot prevention and intervention projects. The MD EIP has also demonstrated that is capable of rapidly responding to emerging infectious disease threats, as seen during the 2003- 2004 seasonal influenza and 2009-2010 pandemic H1N1 influenza seasons. The Maryland EIP currently conducts active, population-based surveillance for the six Active Bacterial Core surveillance (ABCs) pathogens; the nine pathogens of the Foodborne Diseases Active Surveillance Network (FoodNet); and influenza. For most of the ABCs pathogens and all of the FoodNet pathogens, surveillance is conducted state-wide. Maryland's 2009 population was estimated to be 5.7 million, which represented a 7.6% increase since 2000. Active- population-based surveillance for seasonal influenza has been conducted in the six jurisdictions of the Baltimore Metropolitan Area (Anne Arundel, Baltimore, Carroll, Harford, Howard Counties and Baltimore City). During the 2009 H1N1 influenza pandemic, in addition to the on- going surveillance activities, MD EIP conducted active surveillance for Guillain-Barre syndrome state-wide and collected limited influenza surveillance data from the 18 non-BMA jurisdictions. In addition to these surveillance activities, MD EIP conducts a number of surveillance-based special studies including: a study to evaluate the effectiveness of the 4-valent meningococcal conjugate vaccine; molecular surveillance of Neisseria meningitides; geotemporal analysis of meningococcal clones; a study to evaluate the effectiveness of the 13-valent pneumococcal conjugate vaccine; a retrospective review of cases of early-onset Group B streptococcal (GBS) disease; Escherichia coli O157:H7 cohort and genomics studies; retail foods study; a study to evaluate the effectiveness of the influenza vaccine; and case-control studies of previously health children and asthmatics with severe influenza illness. The MD EIP has also received funding to conduct a number of other projects including: • Healthcare-Associated Infections o Hospital-wide prevalence survey of infections and antimicrobial use o National Healthcare Safety Network (NHSN) denominator simplification project o Active, population-based surveillance for candidemia o Active, population-based surveillance for Clostridium difficle infections • Tickborne Diseases o Assessment of underreporting of tickborne infections o Tickborne disease prevention study • Site-specific o Impacts of Good Agricultural Practices (GAPs) on Salmonella Contamination on Maryland Tomato Farms Need Over the past few years, the MD EIP has taken on an ever increasing number of projects. Although the EIP public health and academic staff are well-trained, highly skilled, and extremely dedicated, the rapid expansion of this program has created several areas within the basic infrastructure that are in need of additional support. The first of these is a need for additional high-level academic support in the areas of statistical analysis, sampling strategies, geocoding and spacial analysis, and scientific leadership, including scientific writing. Identifying state- specific sampling strategies that are both representative of the underlying population as well as large enough to sufficiently power the study is crucial for all the EIP special studies. In addition, many of the project areas (e.g. influenza) are using geocoded EIP surveillance data as the basis for linking to other data sources (e.g. census) that may provide additional information re risk factors, environmental exposures, and demographic data for these cases. Given the wealth of EIP data and the increasing complexity of study designs, individuals with expertise in statistical methods and analysis will be instrumental in the development of protocols, manuscripts and reports of EIP findings. To meet these needs, the MD EIP is requesting support to expand the existing relationships with its current academic partners - the Johns Hopkins University, Bloomberg School of Public Health (JHSPH), and the University of Maryland, School of Public Health (UMSPH), with a particular focus on influenza and FoodNet projects, but with flexibility to support aspects of ABCs, HAI-CI, TickNet, and cross-cutting activities as well. We are also requesting funding for one support staff to assist with scheduling meetings, faxing documents, arranging for medical record reviews, copying, filing, ordering supplies, and entering data for the MD EIP staff. The need for additional knowledge in the areas of public health informatics, use of geographic information system (GIS) software, and management of electronic data systems have also been identified as cross-cutting areas needing additional support. To optimize the use of existing information technologies and envision innovative ways in which emerging technologies can be used to support EIP activities, it is important that program staff have an understanding of public health informatics. The state health department is engaged in several efforts around health information systems that directly impact EIP surveillance and special studies. DHMH has used the National Electronic Disease Surveillance System (NEDSS) for collecting reports of all communicable diseases since 2004. An electronic laboratory reporting (ELR) system is in the early stages of implementation. DHMH has been receiving standards-based (HL7 2.3.1) ELR from one commercial laboratory (Mayo Laboratories) and is implementing ELR for two laboratories (the State Public Health Laboratory and LabCorp) in the NEDSS Test environment. In addition, DHMH is in the process of setting up ELR with two Maryland hospital laboratories (University of Maryland Medical System and MedStar Hospitals) and is in discussions with two other hospital laboratories (Johns Hopkins Hospital and Sinai Hospital). Of the five laboratories that have transitioned or are transitioning to electronic reporting, three of them send standard HL7 messages with LOINC/SNOMED codes via PHINMS. Geographic information systems have provided a means to not only map EIP surveillance data, but to analyze this data in a spatial context with other data of interest. To maintain and enhance the quality of EIP surveillance data, EIP staff and the supporting IT staff must keep pace with this rapidly changing landscape in the areas of analysis and information technology (IT). The MD EIP is, therefore, requesting support to send staff to informatics, GIS, and other IT courses that support data systems of importance to the success of our EIP. In addition, existing resources are insufficient to permit laboratory personnel to identify and participate in technical development around important new laboratory techniques. This has delayed, for example, the implementation of new testing methods in our laboratory (such as MLVA) for rapidly characterizing bacterial pathogens associated with foodborne illness. The MD EIP is requesting funding to provide training in microbiological and molecular techniques to DHMH laboratory scientists involved in EIP work. Lastly, is the need to provide routine feedback to the many community partners that are crucial to the success of the MD EIP. Each year, DHMH holds a communicable disease conference for staff from the 24 local health departments. The agenda for this conferences focuses primarily on issues that affect the day-to-day functions of local health departments (e.g. changes in case definitions, NEDSS data entry). The MD EIP has provided limited support for this conference over the past two years to engage support from these staff for more rigorous collection of data of import to EIP (e.g. travel history from individuals with foodborne illnesses). However, the MD EIP is dependent on partnerships with many other entities beyond the local health departments (e.g. hospital infection preventionists, clinical laboratorians). Relying heavily on funding from non-EIP sources, the MD EIP has been able to hold a seminar about once every five years to present surveillance and special study findings, as well as to describe new program initiatives, to these partners. The feedback we have received following these seminars has been very positive and has been used by our partners to encourage further cooperation within their facilities. The MD EIP is, therefore, requesting funding to hold annual scientific seminars for these community partners and to expand the target audience to include local health departments, other state agencies (e.g. agriculture) and public health students. Operational Plan The MD EIP proposes to enhance existing relationships with the recently accredited, rapidly growing, University of Maryland School of Public Health. This school is located on the main campus of the University of Maryland and near many federal agencies, such as FDA. Academic programs include epidemiology and biostatistics, public and community health, and applied environmental health. Partnerships with other schools within the University of Maryland system (e.g. School of Medicine) have also been established. The MD EIP has already established a partnership with Dr. Amy Sapkota, who has existing academic projects related to foodborne illnesses, antimicrobial resistance, and molecular epidemiology - and who is currently funded by EIP/FoodNet to examine mechanisms of Salmonella contamination on Maryland tomato farms. Funds would be used to further engage Dr. Sapkota in EIP activities and scientific leadership. She has also agreed to serve as a liaison to other faculty within the school, and we intend to recruit at least one additional faculty member to become substantially involved with MD EIP and provide subject matter expertise, lead the development of manuscripts for publication, and provide training opportunities for public health students. As noted above, this high level involvement will focus on influenza and FoodNet projects, but with also provide flexibility to support aspects (like geospatial analyses and sampling and modeling techniques) for ABCs, HAI-CI, and TickNet. Depending on the available resources, we will support 2-5 EIP epidemiologists to undergo the collaboration between CDC and the American Medical Informatics Association (AMIA) "10 x 10", or similar, public health informatics training. Courses in geographic information systems (e.g. ArcGIS), taught be certified trainers, are offered on a regular basis by Towson University (located about 20 minutes from DHMH) and other health IT-related training is available at the University of Maryland, Baltimore County. Through one of these universities, we intend to offer four, one day, on-site, group trainings to epidemiologic and IT staff supporting EIP-relevant data systems. With adequate resources provided, we also intend to conduct a MD EIP scientific seminar in the summer of each year for infection preventionists, clinical laboratory scientists, local health department staff, other state agencies, and school of public health faculty and staff (approximately 300 individuals). The purpose of this seminar would be to present findings from recent EIP projects and enlist support for new program activities. Presenters would include CDC personnel, MD EIP staff, and subject matter experts. Continuing education credits would be offered for attendees. Proposed project timeline: 2010-2011 • Recruit faculty and actively engage them in MD EIP activities • Hire support staff • Introductory GIS training is completed • Introductory public health informatics course is completed • Two, one day, group training are held for IT staff • MD EIP scientific seminar held for program partners • State public health laboratorian attends one national meeting or training 2011-2012 • Faculty involvement is increased • One epidemiologist from each MD EIP project area (e.g. influenza) attends an introductory spatial analysis training • At least one MD EIP epidemiologist attends public health informatics course(s) • Two, one day, group training are held for IT staff • MD EIP scientific seminar held for program partners • State public health laboratorian attends one national meeting or training Measures of Effectiveness • At least one epidemiologist from each MD EIP project area (e.g. influenza) completes introductory GIS training • At least one MD EIP epidemiologist completes a public health informatics course(s) • At least two, IT trainings are held for epidemiology/IT staff • At least one MD EIP scientific seminar for program partners is held • Each participating faculty member submits at least EIP-related manuscript for publication Each faculty member mentors at least one EIP-related student project Human Subjects These activities do not include research on human subjects Influenza (Activity 4a1 and 4a2) Background and Understanding The Maryland Emerging Infections Program (MD EIP) has conducted active population-based surveillance for laboratory-confirmed influenza hospitalizations since the 2003-2004 influenza season. Initially established to determine the burden of, and risk factors for, pediatric influenza- associated hospitalizations during that season, this effort has matured into a robust system which is integrated with the other components of Maryland influenza surveillance (including laboratory-based virologic surveillance), and which can serve as a platform for a variety of surveillance-related projects, including the proposed "burden projections" project. Since the hospital-based surveillance began during the 2003-2004 influenza season, there have been several expansions to the system. During the 2005-2006 season, the system was expanded to include adult hospitalizations. Active, population-based, surveillance was conducted from October 1 through April 30 in twenty-one acute care hospitals within the six-jurisdiction Baltimore Metropolitan Area (BMA) of Baltimore City and Anne Arundel, Baltimore, Carroll, Harford, and Howard Counties. In response to the 2009 H1N1 influenza A pandemic, and in accordance with the DHMH pandemic influenza plan, MD EIP's hospitalization surveillance system was expanded to year round surveillance at all acute care hospitals state-wide. Extensive chart reviews, however, were conducted only for those patients within the original BMA catchment area. The following tables show the number of laboratory-confirmed hospitalizations by surveillance area and age group and the number of 2009 pandemic H1N1 laboratory- confirmed hospitalizations reported through the enhanced MD EIP surveillance system. All Reported Influenza Hospitalizations September 1, 2009 - April 30, 2010 Adult Pediatric Total EIP Cases (BMA) 634 347 981 Non-EIP Cases (Outside BMA) 428 232 660 Total 1062 579 1641 Confirmed 2009 H1N1 Influenza Hospitalizations September 1, 2009 - April 30, 2010 Adult Pediatric Total EIP Cases (BMA) 341 164 505 Non-EIP Cases (Outside BMA) 272 150 422 Prior to the 2009 H1N1 pandemic, EIP surveillance allowed for multiple diagnostic tests (e.g. rapid antigen, viral culture) to be used to confirm influenza infection. However, the need for more comprehensive identification of influenza strains - to determine what strains were circulating - led the public health laboratory to enhance capacity to employ RT-PCR techniques that could better characterize different influenza strains/subtypes. By expanding work hours of existing staff to include evenings and weekends, and through the procurement of additional testing equipment, the state public health laboratory was able to temporarily increase its capacity such that all specimens received for influenza testing could be tested with RT-PCR. During the 2009 H1N1 influenza season, the state public health laboratory performed real time polymerase chain reaction (RT-PCR) tests for influenza on over 6,300 respiratory specimens. Of these, 2,320 (36%) were positive for influenza (all types). Of those, 2,284 (98% of positives) were positive for 2009 H1N1 influenza. Four samples were positive for the H3N2 seasonal strain of influenza. Three were positive for type B, and 29 specimens were "equivocal" (where the samples were not of a quality to yield definitive results). To ensure that a specimen was sent to the state public health laboratory for confirmatory and subtype testing by RT-PCR, all cases identified through MD EIP surveillance were checked against STARLIMS (the state laboratory's reporting system), which was updated daily with preliminary and final results. The tables below show the number of specimens submitted for confirmatory testing among EIP (BMA) and non-EIP (outside BMA) hospitalized individuals (respectively). Specimens Submitted for Confirmatory Testing by RT-PCR EIP Non-EIP Total Submitted to DHMH 723 (74%) 353 (53%) 1076 (66%) Submitted to Non-DHMH Lab 0 (0%) 95 (14%) 95 (6%) Not Submitted 258 (26%) 212 (32%) 470 (27%) Total 981 660 1641 The specificity of real-time RT-PCR greatly aided the DHMH and MD EIP's ability to closely monitor the circulating strains of influenza. RT-PCR testing at DHMH was also crucial to appropriately classifying cases for the EIP influenza special studies, including the adult & pediatric H1N1 vaccine effectiveness evaluations and the projects relating to asthma and risk factors for ICU admission among hospitalized healthy children. In addition to the EIP active surveillance and RT-PCR testing activities described above, the Maryland DHMH employed a number of other surveillance systems to monitor influenza activity and distribution, including: the Maryland Resident Influenza Tracking Survey (MRITS), the Outpatient Influenza-like Illness Surveillance Network (ILINet); clinical laboratory influenza testing monitoring; emergency department ILI surveillance, and H1N1- and pneumonia and influenza mortality monitoring. Data from these systems - all of which are now operating year- round in Maryland - were combined with data from other sources to help characterize the burden of influenza in the state. A summary of the data gleaned from these systems is presented below. Influenza Surveillance, Maryland, 2009-2010 PERCENT ILI (%ILI) 18% 16% 14% 12% 10% 8% 6% 4% 2% 0% 60% 55% 50% 45% 40% 35% 30% 25% 20% 15% 10% 5% 0% PERCENT POSITIVE (%POS) 21271714804-MFAJaeapnbyr 131260137-1-M-JJuaunyl 21282595-AS-Jeupgl 1212132482637193-NDFOJaeoecnbvct 216037-MFAeapbyr 15-May WEEK ENDING DATE ILINET %ILI MRITS %ILI ESSENCE %ILI RAPID TEST %POS MRITS is an on-line survey of Maryland households that is the only near-real time component of Maryland influenza surveillance that captures ILI data from people who never seek medical care. Heads of households report weekly on the number of persons in their household with ILI. About 1,600 Maryland residents participate in the system, comprising about 600 households. During the 2009-2010 influenza season, a total of 876 participants reported having symptoms compatible with ILI. Approximately 2/3 of those people never sought medical care for their illnesses. The highest proportions of participants with ILI were reported in the middle weeks of October 2009. Maryland participates in the national ILINet sentinel provider program. Over the course of the influenza 2009-2010 influenza season, 30 providers in all regions of the state reported a total of 11,268 cases of ILI. The proportion of visits due to ILI was above baseline in Maryland for ten weeks between September and November 2009, with the highest proportion of ILI visits reported during the last week of October 2009, when the weekly ILI proportion was over 7%. The majority of ILI cases were in the 5 to 24 age group, followed by the 25 to 64 age group. The Maryland ILINet network includes a variety of practice types and settings. Certain providers may be over-represented in ILINet, so,the reported data may not be representative of the true influenza age group distribution in the population overall. In addition, DHMH monitors clinical laboratories throughout t state. Thirty clinical laboratories located in hospitals, clinics, and physician offices participate by reporting each week the number of rapid influenza tests they performed and the proportion of those tests that are positive. The highest numbers of tests, total and positive, were reported during the middle of October 2009. During the week ending October 24, 2009, over 9,300 rapid tests were reported by 28 of the clinical labs, of which 2,236 (24%) were positive. Similar proportions have been observed in previous influenza seasons, although later in the season. DHMH monitors hospital emergency departments for ILI using the Electronic Surveillance System for the Early Notification of Community-based Epidemics (ESSENCE). The system looks at, among other things, chief complaints of people visiting emergency departments in all Maryland hospitals. Each chief complaint is classified into a syndrome, including ILI. During the 2009-2010 influenza season, over 1.5 million visits to emergency departments were monitored through ESSENCE. Of those, 44,576 (2.9%) were for ILI. The highest proportion of visits for ILI was reported during the week ending October 24, 2009. Finally, influenza-related deaths are monitored using vital records and medical examiner reports. Since May 2009, of the more than 51,000 deaths occurred in Maryland, approximately 4,300 were classified as pneumonia or influenza deaths. About 6% were persons aged 0-24 years old; another 18% were adults less than 65 years old. There were 45 laboratory-confirmed pandemic H1N1-associated deaths in Maryland residents, 4 (9%) of whom were children <18 years old and 33 (73%) were known to have had at least one underlying risk factor for influenza complications. The MD EIP proposes to continue to support RT-PCR testing by the state public health laboratory of specimens from laboratory-confirmed hospitalized cases of influenza. In addition, the MD EIP proposes to collaborate with CDC and other EIP sites to refine the 2009 H1N1 pandemic influenza pyramid model for use during seasonal influenza seasons Need During the recent pandemic influenza event, the DHMH Laboratory promptly provided accurate surveillance testing results that were used to guide decisions to protect public health. However, during the height of the season, this could only be accomplished by having laboratory staff work long shifts and/or on weekends. The ABI 7500 DX instruments were purchased during the pandemic season to run the CDC developed influenza PCR test kits and increase throughput. However, due to the timing of this federal, non-EIP, funding stream, the state public health laboratory was unable to procure service agreements. The FDA, however, requires that for the ABI 7500 DX instruments to be used for running the CDC developed influenza PCR test kits, they must be under the instrument manufacturer's service agreement. Maintaining these instruments in operational order is necessary to test specimens from hospitalized patients for the EIP influenza surveillance activities. The MD EIP is therefore requesting funding to support a full-time position to conduct the additional surveillance testing, to provide required service contracts on real-time PCR instruments that run the CDC developed influenza tests, purchase reagents and supplies to conduct FDA approved multi-plex PCR tests for other respiratory pathogens and/or to isolate viruses in cell culture for further characterization. The MD EIP is also requesting funding to for a courier service to increase the number, and facilitate the rapid transport, of the respiratory specimens collected at hospitals in the Baltimore Metropolitan area to the DHMH Laboratory. It has been determined that existing staff should be able to obtain and transmit to CDC the data needed for the burden projections project; however, additional scientific leadership is needed for this project and has been requested in the "Infrastructure" section of this proposal. In particular, we seek support for academic partners who can determine how existing data might be used to help with burden projections and who can assist locally and EIP-wide with modeling techniques and strategies for this project (and potentially other EIP projects as well). Operational Plan The Maryland public health laboratory is planning to sustain the necessary laboratory infrastructure, personnel, reagents and supplies to conduct active influenza/respiratory virus surveillance by testing specimens collected from severely ill hospitalized patients. The DHMH Laboratory has extensive experience using both molecular and conventional testing method to detect, type and further characterize (i.e. anti-viral drug resistance testing) influenza and other viral respiratory pathogens. The MD EIP will develop a tracking system to monitor the proportion of isolates submitted for surveillance cases by hospital and the time from specimen collection to date results are reported. This system will be used to enhance overall surveillance efforts. The MD EIP will collaborate with CDC and other EIP sites to develop burden projections and modify the "pyramid" multiplier model (Estimates of the Prevalence of Pandemic (H1N1) 2009, United States, April-July 2009: Carrie Reed, Frederick J. Angulo, et. al) in order to estimate the number of cases, hospitalizations and deaths due to seasonal influenza. In particular, in accordance with protocols developed by CDC and EIP sites, MD EIP staff will secure data that permit: 1) the measurement of the incidence of pneumonia and influenza in hospitalized persons; 2) measurement of the proportion of patients hospitalized with pneumonia or influenza who have testing for influenza performed (and the types of tests used); 3) calculation of the numbers and age-distribution of deaths with lab-confirmed influenza; and 4) measurement of the incidence of influenza-like illness in the BMA and the proportion tested for influenza. To support this work, in addition to data obtained from hospitals and the public health laboratory, MD EIP staff will have access to other health department data, including data obtained from the various other state influenza surveillance systems (e.g. EIP hospitalization, ILINet, MRITS), Maryland vital records, and the Maryland Behavioral Risk Factor Surveillance System influenza module, for use in developing this model. Access to data from other sources (e.g. hospital administrative data) will also be sought, as needed. Academic scientific support in the area of disease modeling will also be provided by faculty at the newly accredited University of Maryland School of Public Health. Burden projections work will focus on the 6-county Baltimore Metropolitan Area, but, where possible, we will look at state-wide data as well, to see if inclusion or exclusion of such data alters any findings. Proposed project timeline: 2010-2011 October - November December - April May - September 2011-2012 October - November December - April May - September Hire and train laboratory scientist Establish specimen tracking system Establish contract with courier service Begin surveillance and laboratory testing Collaborate in modification of burden of disease model Conduct surveillance and RT-PCR laboratory testing Monitor isolate submission Data sources for burden of disease model Finalize surveillance data Provide end of season summary report to hospitals and clinical laboratories ...